Liposomal Amphotericin B and Flucytosine Antifungal Strategies for Talaromycosis (LAmB-FAST)

ABSTRACT
Talaromycosis is caused by the dimorphic fungus Talaromyces marneffei (Tm) endemic in Southeast Asia where
it is a leading the cause of death among patients with advanced HIV disease with a mortality on treatment of
30%. Treatment options are limited to just two drugs: amphotericin B deoxycholate (DAmB) which has substantial
toxicity and itraconazole which has poor bioavailability. Our research team has recently delivered the landmark
IVAP trial demonstrating the superiority of DAmB over itraconazole in survival and rate of fungal clearance,
propelling DAmB as the first-line therapy in 2019. Although highly potent, DAmB infusion over 14 days is
associated with serious toxicity; hence the drug has largely been abandoned in high-income countries. As a
roadmap to identify safer and more effective antifungal strategies, our proposal applies three major advances
made in AIDS-associated mycoses to accelerate treatment for talaromycosis. First, clinical trials in
cryptococcosis show that shorter (5-7 days) courses of DAmB is as effective but less toxic than the standard 14-
day course. Second, the AMBITION trial has shown that a single 10 mg/kg dose of liposomal amphotericin B
(LAmB) is as effective as 7-14 days of DAmB but has 30% less toxicity, leading to rapid endorsement by the
WHO as the first-line therapy for cryptococcal meningitis in 2022. Third, addition of flucytosine (5FC) to DAmB
has been shown to be safe, improves fungal clearance and survival. These advances in cryptococcosis lead us
to hypothesize that 1) a single 10mg/kg dose of LAmB will be superior to 14 days of DAmB and 2) the addition
of 5FC will be superior to DAmB or LAmB alone in Tm complication free survival. We will build on our experience
in leading the five-center IVAP trial in Vietnam to conduct a factorial, partially placebo-controlled trial to test two
hypotheses within one LAmB-FAST trial, thus cutting time to knowledge and cost by half. We propose three
related but independent specific aims:
AIM 1. Determine if a single 10mg/kg dose of LAmB is superior to 14 days of DAmB in Tm complication-free
survival. AIM 2. Determine if combination therapy with 5FC is superior to DAmB or LAmB alone in Tm
complication-free survival. The primary outcome for both aims 1 and 2 is hazard of a composite of death, Tm
complications, and AEs grade 3 or higher. Secondary outcomes include: 1) All-cause mortality; 2) Fungal
clearance rate over first 14 days; 3) A novel 4-scale hierarchical outcome of i. Mortality, ii. Tm complications, iii.
AE grade 3, iv. Quality of life scores; 3) Rates of Tm DNA and Tm antigen decline over first 12 weeks. In AIM 3,
we will leverage rare access to a well-characterized and treated talaromycosis cohort to conduct a follow-on
nested randomized controlled sub-study testing whether a HIV viral load guided strategy of stopping itraconazole
chemoprophylaxis (STOP SHORT) is non-inferior the current CD4 guided strategy in the prevention of
talaromycosis relapse and death.
Impact statement. The results of this trial are likely to change treatment guidelines for talaromycosis.

Public health relevance
PROJECT NARRATIVE This clinical trial proposal seeks to inform guidelines on the induction and maintenance therapy of HIV- associated talaromycosis and will answer three questions: 1) Is induction therapy using a single 10 mg/kg dose of liposomal amphotericin B is more effective than 14 days of the conventional deoxycholate amphotericin B; 2) Is adding flucytosine to amphotericin B more effective than amphotericin B alone?; and 3) Is HIV viral load guided stopping of itraconazole maintenance therapy as effective as the current CD4 guided strategy in prevention of disease relapse?